Improving Cardiac Microenvironment as a Novel Strategy against Diabetic Ischemic Heart Failure

PROJECT SUMMARY
Type 2 diabetes leads to greater morbidity and mortality of ischemic heart failure (IHF) with incompletely
understood mechanisms. Recent studies show that diabetes reduces the effectiveness of treatments that work
in nondiabetics, leading to a `universal resistance' condition that worsens IHF. However, advancements in
cellular secretome research highlight the crucial role of the local microenvironment in influencing disease
progression and treatment efficacy. This proposal aims to leverage these insights to transform treatment
strategies for individuals with diabetic IHF. Cardiac secretomes, known as “cardiokines”, are crucial in
maintaining a healthy cardiac microenvironment. C1q/tumor necrosis factor-related protein-9 (CTRP9), a new
identified cardiokine, is a potent cardioprotective molecule that is significantly downregulated in diabetic animals
and patients. Our research indicated that CTRP9 reduction resulted in failed cell therapy interventions for diabetic
IHF, while the therapy succeeded in nondiabetic patients. Small extracellular vesicles (sEVs) are key mediators
in cardioprotection during cell therapy. However, how diabetic downregulation of CTRP9 may adversely impact
sEV properties and hinder its cardioprotection in the diabetic population remains unexplored. Seeking an
engineered approach to modify sEV to effectively overcome the challenges of rescuing the compromised
microenvironment in diabetic IHF is our goal. Our data showed that adipose-derived stromal cells (ADSC) serves
as favarable implantable parent bioresources produces potent sEV. Genetic engineering to overexpress N-
cadherin (Ncad), the receptor of CTRP9, in ADSC (termed NOE-ADSC) significantly enhances their
cardioprotective effects. Currently there is a lack of efficient methods to increase sEV surface protein. It is worth
noting that our approach demonstrated that CTRP9 stimulates the surface adiponectin level on sEV derived from
parent NOE-ADSC. Hence, we poisted a novel hypothesis that “Diabetic downregulated CTRP9 and its receptor
impairs sEV production and diminishes cardioprotection, while administering CTRP9 to enhance sEV generation
from NOE-ADSC, which serve as parent bioresources suprior to sEV alone, represent a novel intervention against
diabetic IHF, providing synergistic protection through CTRP9 and adiponectin. To test this novel hypothesis, we
will complete 3 specific aims. Aim 1 will provide in vivo evidence that bioengineered sEV is the causative factor
responsible for NOE-ADSC cardioprotection against IHF. Aim 2 will prove that cardionyocyte-generated CTRP9
is essential for NOE-ADSC sEV production and cardioprotection, diabetic downregulation of CTRP9 is causatively
related to the incapability of sEV production and resistance to the therapy effect in the diabetic heart. Aim 3 will
illustrate the underlying mechanisms that sEV surface adiponectin (APN) is responsible for NOE-ADSC-sEV
cardioprotection, and the administration of bioengineered sEV parent bioresources NOE-ADSC may be a novel
strategy against diabetic IHF. Therefore, this study will reveal a novel mechanism for the diabetic IHF and identify
new therapies (sEV bioengineering modification) against post-MI remodeling in diabetic patients.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes significantly worsens the outcomes of ischemic heart failure (IHF), presenting complex challenges in therapeutic interventions. Our research suggests that the downregulation of the cardiokine CTRP9 in diabetic patients diminishes the effectiveness of cell therapies, which work well in non-diabetic cases. This proposal centers on demonstrating how diabetes-disrupted cardiac microenvironment and seeks a novel protective strategy through the bioengineering of small extracellular vesicles (sEVs) produced by favorable parent adipose-derived stromal cells (ADSCs) with a protein corona enriched with adiponectin. By genetically enhancing the expression of N-cadherin (Ncad), the receptor for CTRP9, we aim to strengthen sEV production/property and restore cardioprotection in diabetic ischemic heart failure by revitalizing the impaired CTRP9 signaling pathway, ultimately improving treatment outcomes for this condition.